Targeting NINJ1-mediated Plasma Membrane Rupture to Prevent Thrombosis

Project Summary/Abstract
This proposal focuses on investigating the role of plasma membrane rupture (PMR) of pyroptotic macrophages
in thrombosis and examine the potential therapeutic approaches targeting pyroptosis and PMR. Thrombotic
complications remain a leading cause of morbidity and mortality worldwide. Current antithrombotic therapies
target platelets and the coagulation cascade, common pathways for normal blood clotting upon injury
(hemostasis) and the pathological formation of blood clot (thrombosis). These treatments often carry bleeding
risks by disrupting hemostasis and do not address the inﬂammatory roots of thrombosis. Inﬂammation-
dependent blood clotting is part of the body's response to pathogens, but excessive inﬂammation can result in
thrombosis. Emerging research underscores inﬂammation's pivotal role in thrombosis across various conditions,
including heart disease, deep vein thrombosis, sepsis, and COVID-19. Targeting PMR offers a strategy to
simultaneously manage inﬂammation and thrombosis while preserving normal clotting mechanisms. Pyroptosis,
a lytic form of cell death in monocytes/macrophages triggered by inﬂammasomes, is crucial in responding to
bacterial infection and sterile inﬂammation, with PMR being a terminal event in this process. Our previous
research has identiﬁed macrophage pyroptosis as a key contributor to thrombosis, through the release of
microvesicles containing tissue factor (a key initiator of the coagulation cascade together with factor VII/VIIa).
This mechanism is linked to PMR, highlighting PMR as a potential trigger of thrombosis and as a desirable
inﬂammatory target. Because it is the ﬁnal step in a chain of inﬂammatory processes, targeting PMR may carry
low risk of immunosuppression. NINJ1, initially identiﬁed in nerve injury, emerges as the executioner of PMR
that was previously thought to be passive and uncontrollable. This discovery unveils a potential new target for
thrombosis intervention. Our preliminary studies showed reduced NINJ1 expression decreased thrombosis and
the release of pyroptotic microvesicles. This research aims to investigate the role of myeloid NINJ1 in
thrombosis, the mechanisms behind the release of pyroptotic microvesicles, and the feasibility of targeting
pyroptosis and NINJ1-mediated PMR for thrombosis prevention. The expected results will enhance our
understanding of NINJ1-mediated PMR in immune cell-induced thrombosis, potentially leading to targeted
treatments for thrombosis-related conditions like heart disease, venous thromboembolism, cancer, and
infectious disease.

Public health relevance
Project Narrative This study aims to understand how a cell death program called pyroptosis in immune cells can lead to dangerous blood clotting, which is a common problem in cardiovascular diseases and bacterial infections. We've discovered that when the cell membrane ruptures in immune cells through pyroptosis, they release tiny particles that promote blood clot formation. We're investigating a way to stop this process to prevent abnormal blood clots and thus improve the treatments for cardiovascular diseases and bacterial infections.